Non-canonical roles for AMPK and TBK1 in amino acid sensing by mTOR

Abstract
Cellular and organismal homeostasis requires the integration of diverse environmental cues by cell
signaling networks, the disruption of which contributes to pathological conditions. The kinase mTOR, which
comprises the catalytic core of two distinct complexes (mTORC1 and mTORC2), responds to nutrients (amino
acids (AAs); glucose), growth factors (EGF), hormones (insulin), and energetic stress to control fundamental
cellular processes that impact cell metabolism, growth, proliferation, and survival. Not surprisingly, aberrant
mTOR signaling contributes to diverse pathologic states including type II diabetes, cancer, and immune and
neurodegenerative disorders. Despite the physiological importance of mTOR, major gaps exist in our
understanding of mTOR regulation and function, in particular how mTOR communicates with other regulatory
systems. Our research focuses on how non-canonical functions of the energy sensing kinase AMPK and the
innate immune kinase TBK1 control mTOR signaling and function in cells and in mice in vivo. While it is well-
established that AMPK inhibits mTORC1 during energetic stress, our prior work revealed that AMPK
paradoxically i) phosphorylates mTOR on a site that promotes mTORC1 signaling and ii) supports mTORC1
signaling during prolonged amino acid (AA) deprivation, a stress condition that induces autophagy and liberates
AAs, a nutrient that supports mTORC1 signaling in response to growth factors and hormones. These results
reveal AMPK as a previously unknown sensor of cellular AA levels. Thus, this proposal will define how AMPK
supports mTORC1 signaling and function in specific cellular contexts rather than universally opposing mTORC1,
which would invoke a paradigm shift to the AMPK and mTOR fields. While TBK1 is best known to initiate host
defense responses against microbial pathogens, TBK1 also contributes to tumorigenesis and glycemic control
during obesity. How TBK1 mediates these non-canonical processes remains poorly defined, however. Our prior
work revealed that i) TBK1 phosphorylates mTOR to promote mTORC1 and mTORC2 signaling in response to
microbial-derived signals and insulin and ii) the TBK1-mTOR axis protects against hyperglycemia and insulin
resistance in obese but not lean mice. Our preliminary results also indicate that AAs increase TBK1 activity,
revealing TBK1 as another previously unknown sensor of cellular AA levels. Thus, this proposal will also
determine how AAs increase TBK1 activity to promote mTORC1 signaling and better define how the TBK1-
mTOR axis promotes glucose homeostasis and insulin sensitivity in specific physiological contexts, i.e., in the
obese but not lean state. This research will provide conceptual advance, as it will shift how we think about AMPK
and TBK1 in metabolic control and their relationship to mTORC1. Molecular understanding of mTOR network
regulation and how mTOR engages in crosstalk with other signaling systems will provide critical insights that will
advance our understanding of mTOR in health and disease, which may identify new therapeutic targets for
treatment of mTOR-linked disorders.

Public health relevance
Project Narrative The conserved kinase mTOR integrates diverse signals to maintain cellular homeostasis, and defects in mTOR signaling contribute to type II diabetes, cancer, and neurodegenerative and immunological disorders. To better understand mTOR regulation and function, our work investigates how mTOR communicates with other important signaling systems, with a current focus on the energy-sensing kinase AMPK and the innate immune kinase TBK1, signaling proteins linked to disorders also controlled by mTOR. By studying how AMPK and TBK1 control mTOR signaling and function in cultured cells and genetically modified mice, we hope to fill gaps in knowledge regarding the complex regulation of mTOR and identify new therapeutic targets for treatment of mTOR-linked disorders.